PDGFD regulates a transcriptional network to modulate smooth muscle cell transition and coronary artery disease risk

We have identified TCF21 as the coronary artery disease (CAD) associated gene mapped by genome-wide
association studies at 6q23.2 and employed numerous mechanistic approaches to show that it promotes a
smooth muscle cell (SMC) transition to a fibroblast like “fibromyocyte” phenotype, and the contribution of these
cells to the protective fibrous cap. Our studies with another CAD associated gene, the aryl hydrocarbon
receptor (AHR), have characterized the transition of SMC to a second, chondrogenic “chondromyocyte”
phenotype. To extend this work and investigate the mechanisms of epigenetic signaling upstream of TCF21,
AHR, and other factors that mediate SMC cell state, we are focusing efforts on the CAD associated platelet
derived growth factor D gene (PDGFD). We have shown that PDGFD regulates TCF21 and other validated
CAD genes including LMOD1, CXCL12, and SMAD3, and is expressed primarily in disease transition SMC that
also express the PDGFRB receptor. Together, these data suggest that PDGFD activates an autocrine
signaling pathway that modulates SMC phenotype and CAD risk. The hypothesis directing this research
postulates that PDGFD promotes CAD risk through its regulation of TCF21 and other key disease
related transcription factors that mediate the SMC phenotypic response to vascular stress. The primary
goals of the work proposed here are thus to identify the PDGFD target transcription factors (TFs) that regulate
SMC transitions and characterize their transcriptional program in this cell type. Specifically, in Aim 1 we will
employ Pdgfd knockout and SMC lineage tracing in the ApoE null mouse atherosclerosis model to characterize
the effect of this gene on SMC cell state transitions, and the impact of perturbing these transitions on disease
morphology and cellular anatomy. In Aim 2, we will conduct single cell RNA sequencing (scRNAseq) in Pdgfd
null and wildtype atherosclerotic mice to characterize the SMC gene expression program downstream of Pdgfd
in this cell type. Single cell ATAC sequencing (scATACseq) in the same animals will map enhancers genome-
wide that are differentially regulated in SMC phenotypic transitions, and identify specific TFs that bind these
enhancers to regulate expression of fibromyocyte and chondromyocyte specific genes. In Aim 3, we will
perturb candidate SMC transition promoting TFs that are identified in Aim 2, in vitro in a PDGFD stimulated
human coronary artery smooth muscle cell de-differentiation model, and the resulting transcriptomic and cell
state effects interpreted in the context of PDGFD function in this model. These studies will link PDGFD to CAD
associated genes that we have characterized in the context of SMC phenotypic transition (TCF21, AHR,
SMAD3, TWIST1), and to additional high probability CAD genes that regulate SMC phenotype, to expand the
disease transcriptional network in this vascular cell type. This work will advance our understanding of
atherosclerosis pathophysiology and promote efforts to target vascular wall molecular processes to ameliorate
CAD risk.

Public health relevance
NARRATIVE (Public Health Relevance) Significant expense and effort by groups of scientists around the world has led to identification of regions of the human genome that are associated with the genetic risk for various forms of cardiovascular disease, including coronary artery disease. Additional research is required to understand the specific genes involved, and how they work to contribute to the disease process. Such information will allow for better risk assessment and the development of better therapeutics for these diseases.